Evaluating the role of the tumor macroenvironment in cancer cachexia

Project Summary
Cancer cachexia is a severe metabolic syndrome characterized by muscle and adipose wasting. It is a
significant complication faced by cancer patients that reduces quality of life, limits treatment efficacy, and
accounts for nearly a third of a third of cancer-associated deaths. Despite its prevalence, cancer cachexia
remains untreatable by current conventional means, as its complex multi-organ etiology is poorly understood.
Cachexia involves dysregulated crosstalk between the tumor, the tumor microenvironment (TMiE), and organs
essential for energy homeostasis including muscle, adipose, the liver, and the brain. Thus, examination of the
broader tumor macroenviornment (TMaE) is critical. Using pancreatic cancer as a model system, this proposal
aims to elucidate the mechanisms by which cancer cells and the TMiE coordinate with the TMaE to drive
cachexia, thereby identifying novel therapeutic targets for intervention. In the F99 phase, I will investigate the
tumor-TMiE interaction focusing on how tumor-associated macrophages (TAMs) contribute to muscle and
adipose wasting. I have shown that TAMs potentiate muscle atrophy via tumor necrosis factor weak inducer of
apoptosis (TWEAK) signaling 1
. My current investigation suggests pancreatic cancer cells recruit and instruct
TAMs to secrete a well-known metabolic regulator, known as Growth and Differentiation Factor 15 (GDF15),
which acts on the hindbrain receptor GFRAL to accelerate cachexia. Specifically, this is carried out via a
cancer cell-derived Colony Stimulating Factor 1 (CSF1 )-dependent mechanism. Genetic manipulation of both
CSF1 and GDF15 successfully modulated cachexia phenotypes in our models. These findings suggest that
targeting TAM-mediated signaling pathways can mitigate cachexia. The proposed experiments in the F99
phase will assess this therapeutic opportunity. In the KOO phase, I will expand the focus to liver-mediated
pathways in cachexia. Like the nervous system, the liver plays a central role in systemic energy homeostasis.
During the early phases of cancer progression, tumor-secreted factors prime the liver for metastasis. I will
address whether early established metastatic priming events can drive the onset of cancer cachexia. This aim
will utilize advanced animal models and metabolic assays to assess liver dysfunction as an early driver of
cachexia. This work will provide a multi-organ perspective on cancer cachexia, unveiling the complex signaling
network involving tumor cells tumor, the TMiE, and the TMaE. The insights from this research will not only
enhance our understanding of cancer cachexia etiology but also identify potential targets for intervention,
ultimately improving the survival and quality of life of cancer patients.

Public health relevance
Project Narrative Cancer cachexia is a debilitating syndrome affecting many cancer patients, leading to severe muscle and fat loss, decreased quality of life, poorer treatment response, and higher mortality rates2 , This research aims to uncover the mechanisms through which tumors and their microenvironments drive cachexia by disrupting systemic metabolism, with a particular focus on their interactions with critical metabolic regulatory organs (i.e. the TMaE). By identifying novel therapeutic targets, this work has the potential to improve treatment outcomes, well-being, and survival for cancer patients, addressing a critical public health need.